Administrative Core

The purpose of Core B, the administrative core, is to provide programmatic direction, promote interaction among the investigators as well as the consultants and provide administrative budget management. The Program director will plan scientific program meetings; coordinate visits by consultants and represent the Program to the Scripps Research Institute administration. RELEVANCE (See instructions): Core B provides necessary adminstrative support for the activities of all components ofthe Program and ensures that resources are properly managed and their use optimized.